Pilot and Feasibility Program

PROJECT SUMMARY/ABSTRACT
The Pilot and Feasibility program at the University of Chicago (UChicago) Digestive Diseases Research Core
Center (DDRCC) for Interdisciplinary Study of Inflammatory Intestinal Disorders (C-IID) is designed to provide a
mechanism to promote new initiatives in digestive diseases (DD)-related research. The overall objectives of this
program are to support investigations which would allow the development of preliminary data sufficient for grant
funding by conventional mechanisms (pilot studies) or testing of an innovative hypothesis which might have
important implications or yield significant results for digestive diseases related research (feasibility studies). Both of
these broad aims have been pursued in the context of research focused on maintenance of homeostasis and an
understanding of the pathobiology that accompanies intestinal inflammation. In the previous two renewal cycles
(2010-2019), 45 P&F projects were awarded, and in the current period (2015-2019), 20 were awarded. The
return on investment (ROI) over the past 10 years has exceeded 20:1. The P&F program remains an
important vehicle for promoting multidisciplinary collaboration and a strong supportive scientific network for the
young investigators funded by this program. Track I (new) investigators are given highest priority, followed by
Tract II (non-DD) and Tract III (DD, new direction) investigators. We are requesting continuing support at the level
of $110,000 per year. The funds will be combined with the $50,000 per year in supplemental funding committed by
the GI section, bringing the total award amount to $160,000 or $30,000-37,500 for each award depending on the
number of awards selected by the External Advisory Board. With the higher award size, the P&F awards are far
more attractive to potential applicants and substantial enough to improve the odds that they will be successful in
obtaining independent federal and extramural funding. A key feature of the program is the multi-disciplinary
nature of the submitted proposals, coming from numerous departments, programs, and institutional affiliate within
the University of Chicago network including the two of the University of Chicago affiliates, Argonne National
Laboratory (ANL) and Marine Biological Laboratory (MBL). This large catchment of investigator talent reflects the
overall scientific diversity of the research base of the C-IID. The P&F program has therefore made a difference for
many investigators, fostered collaboration and interaction, pushed the envelope of scholarship and discovery, and
is one of the jewels of our C-IID program.